Core E: Correlates of Protection

Flaviviruses and alphaviruses are enveloped, single-stranded RNA viruses that cause epidemics
of human disease on a global scale, with new family members regularly emerging and causing
severe disease. The major goal of our Flavivrus and Alphavirus ReVAMPP (FLARE) Center is
to establish optimized design and modular ‘plug-and-play’ technologies for vaccines and antibody
therapeutics against prototype flaviviruses and alphaviruses that can be readily applied to newly
emerging related threats in this family with pandemic potential. Research in the Correlates of
Protection Core E (hereafter, Core E) will use “state-of-the art” immune assays to evaluate
vaccine and monoclonal antibody efficacy and safety against a diverse group of highly pathogenic
flaviviruses (DENV, WNV, and TBEV) and alphaviruses (CHIKV and VEEV) as models for future
emerging agents. Core E, led by Drs. Diamond and DeSilva, with key contributions by Drs.
Cherry, Wang, Shresta, Katzelnick, and Goss, will meet this need by establishing high-throughput
virological and immunological assays to assess potency, breadth and safety of vaccine responses
and monoclonal antibodies. Core E also will leverage the testing of archived clinical specimens
from human arbovirus cohort studies and vaccine trials to validate, benchmark, and improve
existing assays, and to develop new assays. The main mission of Core E will be to support and
guide the five Research Projects and Animal Core D by functionally interrogating monoclonal
antibodies and serum samples from vaccinated animals. Core E also will perform univariate and
multivariate regression analysis on assimilated data to define key immune correlates of protection
or enhancement for different flaviviruses and alphavirus vaccine platforms. Establishing the
immune correlates of protection in animals and their relationship to humans will guide Go/No-Go
decisions in the individual Projects and inform the rapid development of protective vaccines and
antibodies against future emerging flaviviruses and alphaviruses.